Flexible representation of speech in human auditory cortex

PROJECT SUMMARY/ABSTRACT
The mapping from acoustics to linguistically relevant speech categories is not fixed; rather, speech recognition
adapts to listening context. For example, the utterances bear and pear differ by as many as 16 spectrotemporal
acoustic dimensions. The relative importance (i.e., the perceptual weight) of each of these acoustic dimensions
in signaling bear vs. pear changes with contextual factors like whether the listening environment is quiet or
noisy and whether the talker speaks in a native or unfamiliar accent. This flexibility or adaptive plasticity is an
important component of how the brain maintains robust speech perception despite considerable variation in
speech acoustics. Indeed, inflexible sensory processing is implicated as a source of perceptual deficits in both
hearing impairment and neurological disorders. Yet, the neural mechanisms underlying adaptive plasticity in
speech perception are poorly understood. To address this gap, the proposed research will leverage access
deep within human auditory cortex obtained through intracerebral stereotactic electroencephalography (sEEG),
by employing sEEG simultaneously with scalp electroencephalography (EEG) and well-established behavioral
tasks for measuring adaptive plasticity. Aim 1 will invoke adaptive plasticity in speech perception with acoustic
noise or a change in short-term input distributions mimicking an ‘accent’ and will relate behavioral changes in
the perceptual weights of acoustic dimensions relative to baseline (i.e., clear speech) to changes in the neural
response profile across the auditory cortical hierarchy. Aim 2 will quantify the relationships between sEEG and
EEG to establish the extent to which intracerebral signatures of adaptive plasticity relate to scalp EEG
signatures measurable in the general population; this will also facilitate region-specific interpretation of EEG.
The work will provide novel insight into the cortical mechanisms of adaptive plasticity in speech perception,
with implications for neurobiological models and clinical applications. Our innovative combination of
simultaneous scalp EEG with spatially specific, high signal-to-noise ratio sEEG will create a highly informative
link across noninvasive and intracranial electrophysiology. Project completion also will provide the applicant
with training in cognitive neuroscience of speech perception, intracerebral electrophysiology, and approaches
to effectively integrate intracerebral and scalp EEG. This training will complement her strong
engineering/quantitative background and Ph.D. training in auditory temporal coding, scene analysis, and EEG.
This will advance her goal of undertaking a successful independent academic research career in the
neuroscience of human audition and speech perception.

Public health relevance
PROJECT NARRATIVE This project examines the brain mechanisms that support listeners’ ability to flexibly adapt and recognize speech across contextual variations that include challenging, everyday listening conditions such as speech in noise or in an unfamiliar accent. The study results will have important implications for developing rehabilitative strategies for communication disorders that impact speech perception, such as hearing loss, autism, and schizophrenia.